Chemical Biology to Modulate PCSK9 and Treat Atherosclerosis

PARENT GRANT PROJECT SUMMARY/ABSTRACT
Serum low-density lipoprotein (LDL) causes atherosclerotic heart disease. As the LDL receptor (LDLR) on the
liver clears LDL from the blood, upregulating hepatic LDLR reduces both LDL and cardiovascular events. The
self-cleaving protease PCSK9 (proprotein convertase subtilisin/kexin type 9) is a validated therapeutic target; it
chaperones the LDLR for lysosomal degradation, downregulating its function. Antibodies against PCSK9 lower
LDL and improve clinical outcomes, but cost and administration requirements illustrate a need for alternatives.
Liver-targeted siRNA also robustly lowers LDL, but unlike the well-tolerated genetic variants, it removes all
PCSK9 from the cell, raising safety concerns. Though the mechanistic basis for PCSK9's effect on the hepatic
LDLR is well understand, its functions outside this canonical pathway are less clear. Therefore, the overall
goal of our proposal is to develop biochemical tools to mechanistically dissect the biology of PCSK9, so as to
1) anticipate the long-term effects of current anti-PCSK9 therapies and 2) develop the proofs-of-principle for
novel PCSK9-targeting strategies. To this end, we have identified three promising lead compounds that
specifically target intracellular PCSK9. These compounds both inhibit PCSK9 self-proteolysis and also
upregulate LDLR expression. In Aim 1, we will chemically optimize these compounds, confirm the mechanistic
basis of their effects, and validate their function on PCSK9 and the LDLR in an in vivo model. This will
establish novel chemical probes which can be used to study the poorly known function of intracellular PCSK9,
as well as serve as the starting point for an alternative small molecule therapeutic to upregulate the LDLR. We
have also found that additional factors, including heparan sulfate proteoglycans (HSPGs), interact with PCSK9
to modulate its trafficking to the lysosome, suggesting that there are additional drug targets in this pathway. In
Aim 2, we will evaluate the contribution of HSPGs as mediators of the PCSK9 endocytic trafficking required for
LDLR downregulation, both in vitro and in the human. These results will elucidate whether heparins, which are
already approved therapies, could be repurposed to inhibit PCSK9 function. In Aim 3, we will identify and
validate as yet unknown regulators of PCSK9 endocytic trafficking via an unbiased, genome-wide CRISPR
interference screen. These results will help mechanistically define how PCSK9 is trafficked to the lysosome,
provide answers to why PCSK9 only affects certain tissues, and offer potential novel therapeutic targets which
would be anticipated to have similar therapeutic windows to PCSK9 itself. Overall, we expect our study to
provide key information on the safety of long-term PCSK9 inhibition, lay the groundwork for novel treatments,
and identify new therapeutic targets against atherosclerosis.

Public health relevance
PARENT GRANT PROJECT NARRATIVE Successful treatments for atherosclerotic heart disease reduce the “bad” cholesterol in the bloodstream, but further therapies are needed, underscoring the public health relevance of this proposal. These challenges will be addressed by 1) developing a precursor to a small molecule drugs which could reduce these cholesterol levels, 2) evaluating whether there is a scientific basis to repurpose currently approved anticoagulant medications to lower cholesterol, and 3) identifying other factors responsible for elevating cholesterol which could be targets themselves for new drugs. As a result, this proposal is directly relevant to the NIH mission of promoting fundamental discoveries and innovative research designs as a basis for improving human health.